Mechanisms and Evolution of Host Tolerance to Transposable Elements

PROJECT SUMMARY/ABSTRACT
Transposable elements (TEs) are omnipresent genomic parasites, comprising >70% of the nuclear
DNA in certain lineages. In addition to producing deleterious mutations, TEs can exert lethal, genotoxic effects
on host cells by causing double-stranded breaks during insertion and excision. Host genomes have two
mechanisms for avoiding the fitness costs of parasitic TEs: resistance and tolerance. Mechanisms of
resistance reduce TE load by repressing transposition, while mechanisms of tolerance reduce the fitness
consequences of existing TEs. While resistance to TEs is studied extensively, with small-RNAs in particular
emerging as a taxonomically widespread strategy, tolerance is a new concept that I have recently proposed.
Furthermore, through an innovative QTL mapping experiment, I provided critical proof-of-principle for tolerant
genetic variants in Drosophila melanogaster. In the future, I propose to build on these recent discoveries to
expand our understanding of tolerance mechanisms and evolution.
First, we will study the mechanism and recent evolutionary history of bruno-dependent tolerance to P-
element DNA transposons. Bruno is a developmental regulator of oogenesis, which we have recently
demonstrated is a major determinant of female germline tolerance to unregulated P-element transposition. By
combining genetic analysis of mutant alleles, as well tolerant bruno variants we have isolated from natural
populations, we will reveal the underlying mechanism of bruno-dependent tolerance. Furthermore, by taking
advantage of the unique opportunity provided by historic D. melanogaster collections, we will evaluate the
contribution of bruno tolerant variants to the host adaptation to the P-element invasion in the mid 20th century.
My second research direction is motivated by our discovery that natural variation in heterochromatin is
an important determinant of how cells are impacted by unregulated transposition: larger doses of
heterochromatin and reduced heterochromatin formation decrease cellular tolerance. These observations are
reminiscent of Barbara McClintock's “genomic shock” model, in which tremors arising from DNA damage or
cellular stress trigger the release normally quiescent repeats. I therefore propose to interrogate the relationship
between heterochromatic variation and response to genotoxic stress at both the cellular and regulatory levels.
My long-term goal is to reveal complex and intimate relationships between TEs and their hosts, which
contribute to genome evolution and shape the evolution of gametogenesis. A better understanding of these
interactions is of vital importance because: 1) they are the interface at which TEs and host cells coevolve, 2)
TE activity is implicated in the onset, progression of many tumor types and age related neurodegenerative
diseases, and 3) vast differences in TE content and distribution between host genomes remain largely
unexplained.

Public health relevance
PROJECT NARRATIVE Transposable elements are mobile DNA sequences which spread through eukaryotic genomes, making up ~50% of the human genome. The mobilization of transposable elements is implicated in the onset and progression of many cancers, as well as age-related neurodegenerative diseases. The proposed research uses Drosophila melanogaster as a model to reveal the mechanisms and evolution of host cellular responses to transposon mobilization.